Sex Specific Differences in the Remodeling of a Biopolymer Based Tissue Engineered Vascular Graft

PROJECT SUMMARY
Coronary artery disease is the most widespread form of heart disease and is responsible for over 350,000 deaths
per year. CAD is often treated through coronary artery bypass grafting (CABG) with an autologous vessel being
used as the bypass graft. However, there are high CABG failure rates due to issues with graft sourcing and graft
mechanical properties, with failure rates in post-menopausal (estrogen deficient) women being elevated
compared to their pre-menopausal and male counterparts. As a result, the field is working on developing a tissue
engineered vascular graft (TEVG) to replace autologous vessels, yet there has been insufficient
characterizations of sex and menopausal status as variables in successful TEVG integration. Sex differences in
vascular remodeling have been established clinically, with pre-menopausal females having subdued
inflammatory responses in atherosclerotic environments and post-menopausal females having insufficient
vascular smooth muscle cell (VSMC) remodeling in arteriovenous fistulas. This leads us the believe that VSMC
behavior is key in understanding the sex specific differences in vascular grafting outcomes. Our lab has shown
that compliance matched TEVGs (CM TEVGs) have an increased number of VSMCs and a more favorable
inflammatory response than their stiff counterparts in a small animal model. However, we have noticed that CM
TEVGs implanted in female rats show signs of advanced degradation (aneurysm formation, loss or graft
materials) when compared to male rats. This suggests that there are sex specific differences in the remodeling
of biodegradable TEVGs that may reflect sex specific differences seen clinically. We have also shown that VSMC
behavior surrounding our CM TEVGs can be modulated with Transforming Growth Factor Beta 2 (TGFβ2). Low
levels of TGFβ2 elution increases VSMC count within the graft. VSMCs live on a phenotypic spectrum that allows
them to both modulate blood pressure and contraction during homeostasis and increase migration and ECM
remodeling in response to vascular injury. The overarching hypothesis of this work is that the remodeling
rate of CM TEVGs is dependent on sex and that this rate is related to the effects of estrogen on VSMC
behavior. Aim 1 will assess tissue level differences in mechanics and ECM deposition as well as cellular makeup
of CM TEVGs in male and female. Aim 2 will encourage changes VSMC behavior in our CM TEVGs via TGFβ2
to study the effects of estrogen presence on a VSMCs ability to change phenotype in response to vascular injury
in ovariectomized (OVX) rats. OVX rats are a widely used post-menopausal small animal model. The successful
completion of these aims will elucidate the role of sex on VSMC behaviors that are critical to the successful
integration of TEVGs.

Public health relevance
PROJECT NARRATIVE Coronary artery bypass grafting (CABG) procedures have up to a 42.8% failure rate over ten years, with post- menopausal women having the worst outcomes of all vascular graft recipients. As the field moves to develop tissue-engineered vascular grafts (TEVGs) to be used in CABG procedures, sex-specific remodeling of these conduits is not well characterized despite clinical evidence of sex-specific failure modes. The proposed research will investigate both tissue scale and cellular differences in remodeling between different sexes for compliance- matched TEVGs in vivo using male, female, and post-menopausal female rats to elucidate the role of estrogen in successful vascular graft integration.